Evaluating Veterans' Reproductive Healthcare Access, Quality and Outcomes in a Changing Landscape (EVOLVE)

Background: Recent years have witnessed unprecedented changes in the reproductive healthcare landscape
in the US, including heightened awareness of reproductive health inequities following the 2020 nationwide
racial justice reckoning, barriers to access resulting from the COVID-19 pandemic, and the proliferation of state
abortion restrictions and bans following the 2022 Dobbs v Jackson Supreme Court decision. Today, access to
high-quality, equitable contraceptive care has never been more vital for Veterans, who face elevated risks of
poor outcomes from unintended pregnancy due to high rates of health comorbidities and psychosocial risks.
The Examining Contraceptive Use and Unmet Need in Veterans (ECUUN) survey fielded in 2014-16 by study
team members demonstrated high rates of unintended pregnancy and gaps in VA contraceptive access and
quality, with significant disparities among Black and Latinx Veterans. While the ECUUN study helped inform
VA’s reproductive health policies to date, updated data are urgently needed to capture VA’s progress in
addressing disparities over time as well as its ability to meet Veterans’ needs in today’s shifted landscape.
Significance: This study will generate timely quantitative and qualitative data necessary for VA as a learning
health system to address gaps in access and quality and to adapt its policies and programming to meet
Veterans’ changing needs. In addition, this study focuses on contraceptive counseling experiences in
marginalized Veterans, for whom this care may be fraught due to the US history of reproductive oppression
such as forced sterilization and policies to punish or limit reproduction in racial minority and low-income people.
Findings will enable VA to respond to new White House and congressional directives related to women’s
health that call for research to advance reproductive healthcare access and reduce disparities in care.
Innovation & Impact: This proposal is innovative in its timeliness, use of prior data to draw novel comparisons
over time, deployment of new state-of-the-art person-centered measures not yet fielded in VA such as the
National Quality Forum (NQF)-endorsed Person-Centered Contraceptive Counseling (PCCC) measure, and
collection of data to capture experiences of VA’s new policy to provide abortion care in select cases.
Specific Aims: Aim 1: To use quantitative survey data to examine changes over time since ECUUN in
contraceptive use, unintended pregnancy, and abortion, including differences by Veteran characteristics (e.g.,
race/ethnicity, geography). Aim 2: To use quantitative survey data to test for current disparities in novel
person-centered measures (e.g., PCCC) by Veteran characteristics and characteristics of their health care.
Aim 3: To contextualize Aim 1 & 2 findings, including disparities in experiences of contraceptive care and
unintended pregnancy/abortion, by conducting qualitative interviews with Veterans.
Methodology: This is a sequential explanatory mixed methods study beginning with a national survey of 3,600
pregnancy-capable reproductive-age Veterans who used VA primary or gynecology care in the past year.
Qualitative interviews will then be conducted among Veteran survey respondents, purposively sampling at-risk
subgroups (Black, Latinx, rural, residence in abortion-restrictive state) whose survey responses indicate gaps
in care quality or equity. Quantitative data will inform qualitative sampling and data collection, and quantitative
and qualitative data will be integrated using mixed methods analytic techniques including joint displays.
Next Steps/Implementation: Next steps will include conducting a stakeholder engagement meeting with
Veterans, women’s health providers, and operational partners from the Offices of Women’s Health, Health
Equity, and Rural Health to share key research findings, develop strategic goals, and prioritize interventions to
address disparities in contraceptive access and quality. Ultimately, this study has the potential to enhance VA’s
ability to be a national leader in delivering high-quality and person-centered reproductive healthcare and to
inform efforts to advance quality and equity in reproductive healthcare both within and beyond the VA.

Public health relevance
Recent changes in the US reproductive health landscape – including the proliferation of state-level abortion restrictions and bans following the 2022 Dobbs v Jackson Supreme Court decision – hold major implications for reproductive health care and equity. Access to high-quality, equitable contraceptive care has never been more vital for Veterans, who face elevated risks of poor outcomes from undesired or unsafe pregnancy due to high rates of medical and mental health comorbidities and psychosocial risks. Ongoing efforts to address gaps and disparities in VA contraceptive care must be informed by Veterans’ perspectives, experiences, and needs. This study will amplify the voices of Veterans capable of pregnancy through a nationally representative survey and qualitative interviews to understand how their contraceptive needs have changed over time and how well VA is meeting their needs in today’s profoundly shifted landscape. Findings from the study will advance VA’s ability to lead nationally in providing equitable and person-centered reproductive health care.